Multi-Level Interventions to Reduce Caries Disparities in Primary Care Settings

PROJECT ABSTRACT We are requesting an administrative supplement to continue the follow-up visits for the parent UH3 study in order to accomplish the project objectives.

Public health relevance
PROJECT NARRATIVE We are requesting an administrative supplement to continue the follow-up visits for the parent UH3 study in order to accomplish the project objectives, which have not changed.